Investigating the role of dorsal raphe nucleus enkephalin neurons in motivational and affective behaviors during chronic pain

PROJECT SUMMARY
The primary goal of this NRSA F32 proposal is to determine the contribution of endogenous opioids in dorsal
raphe nucleus to motivational and affective dysregulation during chronic pain. Chronic pain is a complex disease
state which is associated with comorbidities such as depression, anxiety, and increased risk of suicide. However,
the primary target of analgesic research has been peripheral and spinal sensory mechanisms despite emotional
unpleasantness being a key feature of the human pain experience. Exogenous opioids are the gold standard for
pain relief but are associated with many negative side effects. The endogenous opioid system is well known to
powerfully modulate both analgesia and affective and motivational neural circuits. It is therefore essential to
understand how this system may be contributing to the emotional component of chronic pain states. Historically,
dorsal midbrain nuclei such as dorsal raphe nucleus (DRN) and adjacent periaqueductal grey have been shown
to be important sites of opioid action. However, the specific role of opioid peptides within the DRN during chronic
pain has not been characterized despite studies showing opioid activity here can also powerfully modulate pain
and motivated behaviors. Preliminary data from our lab indicate that CRISPR-Cas9 disruption of
preproenkephalin (PENK) in DRN enhances aversion. Specifically, DRNPENK knockdown increases allodynia
following a mild acute pain state and decreases time spent investigating an aversive odor. This increase in
aversion is similar to behavioral changes observed in chronic pain states. Therefore, the goal of this NRSA F32
is to determine how DRNPENK contributes to the motivational and affective behavioral dysfunction resulting from
chronic pain. First in Aim 1, we will use dual-color 1-photon endoscopic imaging to examine how enkephalinergic
and non-enkephalinergic neurons encode evoked and non-evoked pain as well as motivational behaviors before
and after the development of chronic pain. In Aim 2 we will determine whether suppression of DRNPENK neuron
activity elicits a pain-like phenotype in naïve animals using designer receptors exclusively activated by designer
drugs (DREADDs). Finally, in Aim 3 we will test the therapeutic potential of activating DRNPENK in a chronic pain
state. We will use DREADDs to activate DRNPENK neurons both with and without CRISPR-Cas9 disruption of
enkephalin peptide to specifically interrogate the function of this peptide in chronic pain-induced behavioral
dysregulation. Together, these studies will provide insight into the role of endogenous opioids within a unique
dorsal midbrain nucleus on motivational and affective behavioral dysregulation during chronic pain. This will lead
to a better understanding of chronic pain pathophysiology and more effective potential neurochemical targets for
therapeutic intervention.

Public health relevance
Project Narrative Chronic pain affects more than 30% of the adult population and often leads to comorbidities such as depression, anxiety and increased risk of suicide. It is now appreciated that chronic pain is associated with dysregulation of affective and motivational circuits in the brain, both of which are highly sensitive to endogenous opioid signaling. Here, we seek to leverage next-generation, opioid specific technologies to determine the biological and computational function of endogenous opioids within the dorsal raphe nucleus in regulating chronic pain-induced dysregulation of motivated behaviors.